Cartilage Developmental Biology And Tissue Engineering

The overall scientific mission of the Cartilage Biology and Orthopaedics Branch is the study of the biology of cartilage tissues and the application of such knowledge to orthopaedic medicine. This project focuses on the mechanism of cartilage development, approaches to cartilage tissue engineering, and the cellular basis of orthopedic implant stability. There are three interrelated parts to the project. (1) Using embryonic skeletal mesenchymal cells and multipotent embryonic mesenchymal cell lines, we have analyzed the role of cell-cell and cell-matrix interactions, growth factors and other signaling molecules, and gene expression and regulation events during chondrogenesis. Topics include: 1) N-cadherin mediated cell adhesion; 2) gap junction communication; 3) cell interaction with fibronectin isoforms; 4) members of the transforming growth factor-beta superfamily, i.e. bone morphogenetic proteins (BMPs) and Growth/Differentiation Factor 5 (GDF5); 5) Wnt family of signaling proteins; and 6) transcription factors, such as cbfa1, AP1, paraxis, scleraxis, and other basic helix-loop-helix proteins. Results from these studies point to the initial cellular condensation event, and the cross-talk of multiple signaling pathways, as a key regulatory events of developmental chondrogenesis. Methods are being developed for efficient gene transduction protocols to modulate the expression of these key factors and to examine the effects on mesenchymal condensation and chondrogenesis. (2) The information gained from these developmental studies are also being applied to the system of adult tissue derived mesenchymal stem cells (MSCs) for the purpose of cartilage tissue engineering. Multipotent MSCs are isolated from bone marrow stroma and from adult trabecular bone and studied in vitro for their ability to undergo multi-lineage differentiation along the osteogenic, chondrogenic, and adipogenic pathways. The mechanism of action of growth factors and hormonal regulators in their differentiation is being analyzed. In addition to establishing protocols to optimize MSC isolation and enrichment, we are developing new methods to construct three-dimensional biodegradable scaffolds to seed MSCs under chondrogenic conditions for cartilage tissue engineering applications. One specifc aim is to fabricate single-unit constructs that can be used for osteochondral implants applicable for cartilage re-surfacing. We believe that the knowledge gained from the study of developmental chondrogenesis will be important in designing approaches to modulate the cellular and molecular activities of chondrogenic MSCs in three-dimensional cartilage tissue engineering. Elucidating the biological characteristics of MSCs and how they respond to environmental signals is therefore fundamental to the advancement of tissue engineering. We are currently developing clonal MSC cell lines harboring differentiation-specific marker gene constructs as “read-out” cell systems as well as gene microarray approaches to profile gene expression profiles during differentiation to identify key regulatory signals. (3) Finally, our recent studies have also addressed the cellular mechanisms responsible for implant wear debris mediated osteolysis, which is primarily responsible for aseptic implant loosening. Specifically, our results indicate that the presence of titanium particulate debris suppresses osteogenic differentiation and enhances apoptosis in cultures of MSCs in vitro, both of these responses likely contributing to compromised periprosthetic osteogenic tissue response and implant loosening. The involvement of specific cytokines and signaling pathways is being investigated. Information gathered from this project should provide a rational basis to functional skeletal tissue engineering.